CORE--BIOSTATISTICAL

An Administrative and Biostatistical Core is proposed to: 1) Provide the administrative infrastructure to aid the SCOR Director and other participants in the coordination of projects/cores in accomplishing the overall scientific goals of this research program; 2) aid the SCOR Director in managing the budget; 3) aid the Director in planning and evaluation of the research program; 4) coordinate interactions between the SCOR and the collaborating institutions; 5) provide a central data collection and coordinating center for the projects/cores which will promote interaction among them and allow the efficient analysis and dissemination of the scientific data generated; 6) the Core will be comprised of the Center Director and Co-Directors, the Biostatistician, and Administrative Assistant, a Data Manager, and the Internal and External Scientific Committee.